A Trial to Explore the Benefits of Antimicrobial Self-Sanitizing Surfaces on Bio-Burden Levels and Healthcare-Acquired Infections.

Prevention of healthcare-acquired infections (HAIs) is a priority challenge. The exact degree to which hospital
surfaces influence the transmission of HAIs is not well understood. Current cleaning procedures such as
sanitation of surfaces in hospital rooms with dilute sodium hypochlorite (bleach) and the use of ultraviolet light,
while efficacious in reducing surface contamination episodically, do not provide continuous antibacterial
activity. Furthermore, due to inadequate manual cleaning, antibiotic-resistant pathogens, such as methicillin-
resistant Staphylococcus aureus (MRSA) and Clostridium difficile (C. diff) can live on surfaces for several
months. Copper has antimicrobial properties against important antibiotic-resistant pathogen. Implementing
copper and copper alloys in surfaces has the promise of continuous microbial killing power in the background
as adjunct to current effective (although intermittent) strategies.
This implementation study will explore the benefit of converting high touch surfaces in patient rooms to
a novel self-sanitizing copper oxide-impregnated solid surface (SSS-Cu) manufactured by EOSCu Surfaces
LLC, Norfolk, Virginia. The SSS-Cu has a uniform distribution of 16%-20% copper oxide. SSS-Cu has proven
to be 99.9% bactericidal within 2 hours in a laboratory setting, has been registered with the Environmental
Protection Agency (EPA) as environmentally safe, and has been associated with a significant decline in HAIs
in a prior study at the Sentara Leigh Hospital, Norfolk, Virginia. The specific aims of our proposed study are to
(1) establish real world effectiveness of SSS-Cu in the prevention of bio-burden accumulation in occupied
patient rooms; (2) establish the effect of SSS-Cu as an adjunct to standard disinfection protocols on HAI rates
for patients admitted to the study hospital; and (3) determine the economic impact of the use of SSS-Cu in the
hospital setting.
A prospective pre-post study design is proposed to compare hospital surface bio-burden and HAI rates
between patient room environments with and without SSS-Cu surfaces. With the installation of SSS-Cu in
acute and critical care rooms, environmental bioburden will be compared before copper surface installation to
after copper surface installation. Further additional samples will be taken at 18 months and 36 months to
evaluate continued efficacy of copper over time. HAI rates among all patients admitted to the hospital for a
three-year period prior to installation of SSS-Cu will be compared to HAI rates among all patients admitted to
the hospital for a three-year period following the completion of installation of SSS-Cu in all acute and critical
care rooms. The setting for this study is a 120-bed inpatient facility that is part of an integrated VA health care
system in Temple, Texas. We expect that SSS-Cu materials will lower environmental bio-burden, lower HAI
rates, and result in significant decreases in infection-associated inpatient healthcare expenditures when
compared to standard, non-SSS-Cu hospital rooms.

Public health relevance
The goal of this study is to explore the effectiveness of a self-sanitizing antibacterial surface that is a blend of copper oxide and polymer in a real clinical setting and assess whether this surface prevents accumulation of bacterial contamination on healthcare surfaces. Our project has the potential to reduce infections resulting from admission to a healthcare facility such as a VA hospital. The impact of this new technology could be transferred to other healthcare settings such as clinics, nursing homes, operating rooms, and other areas including medical care systems in private sector.